Peptidergic Modulation of NMDA-Receptor Mediated Neurotransmission

Synapses control information processing by the nervous system, and dysfunction of synapses is associated
with many neurological diseases and neurodegenerative disorders. In all nervous systems, glutamate is the
primary excitatory neurotransmitter used to activate neurons. The goals of this study are to provide important,
new mechanistic insights into the function of glutamatergic synapses, which will aid in our understanding of
information processing by the brain and provide new avenues for the development of pharmaceutical therapies
for nervous system disorders. Using a genetic platform based on the nervous system of the model organism C.
elegans, we will study how peptide ligands, which signal via G-protein coupled receptors, regulate synaptic
function mediated by NMDA-type ionotropic glutamate receptors (NMDARs). Synaptic NMDARs are involved in
the pathophysiology of numerous psychiatric and neurological disorders. We propose an integrated
multidisciplinary approach that combines in vivo electrophysiological analysis, behavioral studies and
optogenetic to study the mechanism of action by which specific neuropeptides regulate NMDAR-mediated
synaptic signaling. These studies have particular promise for a deeper understanding of nervous system
plasticity, and behaviors such as learning and memory. Our studies will reveal new targets for the development
of new drugs and novel therapeutic strategies for disorders of nervous system function.

Public health relevance
The goals of our research are to identify and characterize the molecular machinery that contributes to synaptic signaling in the nervous system, with a focus on signaling mediated by the excitatory neurotransmitter glutamate and mediated by ionotropic glutamate receptors (iGluRs). Our goal is to obtain a mechanistic understanding of how neuropeptide signaling regulates the function of NMDA-type iGluRs, with a focus on specific peptide ligands and G-protein coupled receptors. These studies could provide new insights into the disordered synaptic function characteristic of many neurological disorders, identify new drug targets for therapeutic intervention, and ultimately contribute to the development of new therapeutic modalities for the treatment of neurological and psychiatric disorders.